Alpha1 Anti-trypsin Enhances Islet Autograft Survival

Project Summary A major challenge in islet transplantation is avoiding early islet destruction and primary nonfunction after intraportal islet infusion. Because of these issues, at least two donors are needed for one recipient to achieve euglycemia after allogeneic islet transplantation (for patients with type 1 diabetes, T1D), and only around 1/3 of patients become insulin-independent after autologous islet transplantation (for patients with chronic pancreatitis, CP). Poor islet graft engraftment after transplantation contributes to the low efficacy of islet transplantation. Alpha-1 antitrypsin (AAT) is a serine proteinase inhibitor that manifests strong anti-inflammatory and anti- apoptotic properties and promotes vascularization. AAT infusion during the peri-transplantation period protects islets from immune rejection and preserves islets/β cell function in mouse, pig, and non-human primate, as manifested in autologous, allogeneic and xenogeneic islet transplant settings. Our parent award was designed to study the mechanistic effect of the human purified AAT, Prolastin-C (Grifols, US) when human islets are transplanted into the diabetic NOD-SCID mice, and to conduct a clinical study to evaluate the therapeutic effects of AAT in the prevention of islet cell death and dysfunction in CP patients undergoing total pancreactectomy and islet autotransplantation (TP-IAT), in a double blind, randomized and controlled study (www.clinicaltrials.gov, NCT02947087). Data from our animal study suggest that AAT increases islet graft survival by suppressing instant blood mediated inflammation reaction (IBMIR), macrophage activation and inflammation after intraportal islet transplantation. In the clinical trial, we have enrolled 24 of 48-targeted patient enrollments. However, no mechanistic studies in human samples were proposed in the parent award to confirm the mechanistic data obtained from the animal studies. Since we are still actively recruiting the last 24 patients to achieve the enrollment goal, we propose additional studies to directly address a gap between our animal studies and the clinical studies by testing the impact of AAT on patients' peripheral blood mononuclear cells (PBMCs), cytokine profiles and β cell death during the peri-transplantation period. We hypothesize that AAT treatment increases β cell survival by changing PBMC profiles and/or gene expressions, and consequently reduces inflammation that may contribute to islet death post transplantation. We estimate that these additional studies will reveal critical information on the mechanistic effects of AAT in human islet transplantation settings.

Public health relevance
Project Narrative The goal of this study is to collect more patient samples and analyze them to gain mechanistic insights on the protective effects of AAT in chronic pancreatitis patients undergoing total pancreatectomy and islet transplantation. The extra data gained will greatly increase the parent award's overall impact by providing a more comprehensive and rich picture of AAT therapy in the context of a highly novel and innovative clinical intervention.